Conference on the Biology of Aging

DESCRIPTION (provided by applicant): We are requesting partial support for the Biological Sciences component of the Year 2004 Annual Meeting of The Gerontological Society of America (GSA). The theme of this conference, selected by the incoming President, Dr. Terrie T. Wettle, is: "Promoting the Health of an Aging Population." Nine invited symposia have been organized with the aim of bringing the latest research into the Biology of Aging to a diverse audience of research biologists, clinicians, and interested health professionals. The topics of these symposia aim to stimulate exciting scientific interchange and to provide synthesis and consolidation to emerging data on the genetics, biochemistry, cell biology, and physiology of general patterns of aging. The principal part of this application is to request funding for these symposia. Our principal objective is to provide conferees with a stimulating and provocative set of presentations and critical dialog on state-of-the-art current research in the basic biology of aging, as well as to introduce emerging strategies that are likely to facilitate the translation to healthy aging of our population. Ongoing molecular investigations in diverse model systems have enhanced our understanding of the mechanisms and consequences of aging. These insights need to be shared and discussed. As a consequence of this better understanding, methods of intervening in the aging process are being continually refined, and these tools also need to be widely shared and discussed. The broad field of biogerontology is beginning to show some unifying conceptual themes, and, if so, they will be discerned in the increased overlap and interconnectedness of previously discrepant research areas. The goal of this meeting is, therefore, to provide a forum for the dissemination of information, and more importantly to promote dialog in research areas and methods, which (1) have not recently been covered at GSA meetings, and (2) offer the prospect of making significant advances in our understanding of the mechanisms that promote or retard aging.